Clinical and Translational Science Award

The Einstein-Montefiore Institute for Clinical and Translational Research (ICTR) has evolved over the past two
CTSA funding periods, embracing the broad spectrum of clinical and translational (C/T) biomedical research
from T1 through T4. We have provided pathways for our clinicians and our integrated healthcare system to
expand implementation science, population health, community-engaged research, and clinical trials while also
encouraging basic scientists to innovate new therapeutics and diagnostics. This broad involvement with our
community and investigators has allowed the CTSA to impact a wide range of research extending from drug
design and improving clinical trials management, to training a new research workforce, and to using
implementation science for community-engaged and healthcare research. Indeed, the ICTR’s mission—to
advance research across the translational spectrum into clinical practice through its integrated infrastructure,
innovative training, and institutional co-investment—has evolved in step with that of the National Center for
Advancing Translational Sciences. In this application, we will 1) leverage CTSA resources with institutional
assets that support state-of-the-art informatics to accelerate the transfer of discoveries to healthcare via an
Evidence Generation Framework, and support regulatory streamlining, innovative analytics, and assist with all
phases of C/T research; 2) develop the next generation of research workforce and teams, using novel
education, training, mentoring, pilot study support, and career development resources that span translational
domains; 3) expand collaborations and engagement, both with the CTSA network and other hubs, and the
Bronx community and healthcare partners in an integrative paradigm with strategies developed in collaboration
with community partners, investigators, and institutional leadership to improve population health; 4) advance
life span, child health, and aging research across genders and special populations, by working with unique
platforms for stakeholder-engaged research, patient safety and implementation science, the Montefiore
Accountable Care Organization, and the New York City Practice-Based Research Network; and 5) innovate
methods and processes that advance C/T sciences, and enhance quality, safety, and efficiency of C/T
research. We will integrate the CTSA Trial Innovation Network into our ecosystem of multisite clinical trials,
foster innovative methods for biomarker assays and biobanking for precision medicine, and leverage the CTSA
Common Metrics Initiative to support our hub’s Evaluation and strategic management. Overall, the Einstein-
Montefiore ICTR will fulfill NCATS’s tripartite mission to innovate, educate, and implement.

Public health relevance
The Einstein-Montefiore Institute for Clinical and Translational Research (ICTR) supports laboratory and clinical research investigators working to bring new treatments to the public more quickly, safely and efficiently with the overall goal of improving population health. The mission of the ICTR is also to train the next generation of clinical and translational research teams so that they develop the competencies to apply new knowledge and processes, as well as to expand collaborations with the community and healthcare partners.